Identifying germline pathogenic variants in familial lung cancer among African-Americans

ABSTRACT
Lung cancer (LC) is the third most common cancer in the U.S. with African Americans (AAs) having the highest
incidence and mortality. While previous linkage, admixture, exome sequencing, and genome-wide association
studies in European-Americans and Asian ancestry show statistically compelling effects, much of LC heritability
in AAs is yet to be explained. Genetic Epidemiology of Lung Cancer Consortium (GELCC) is the only consortium
in the U.S. that studies Familial Lung Cancer (FLC) families, but to date, the majority of data collection and
analyses are of European-American (EA) ancestry.
Our recent cross-ancestry genome-wide meta-analysis has shown that the genetic architecture of minority
populations is distinct for LC risk in the general population. Previous studies have shown differences in allele
frequencies due to differences in racial ancestry are more pronounced for rare variants. Our GELCC family-
based studies have identified several very rare, high-risk pathogenic variants in EA families. However, no family-
based LC study has been explored in the AAs because of the extremely low number of AA families and limited
accessibility and availability of biospecimens.
This application will capitalize on existing Whole Genome Sequencing (WGS) data from the valuable collection
of GELCC AA families (120 FLC cases and 146 unaffected family members), 282 high-risk sporadic LCs with
family history of LC or early-onset, and 154 unrelated controls. To increase power, especially in rare variant
discovery where AA FLC families are limited, we will also utilize
publicly available WGS data from the All of Us,
one of the most racial/ethnically diverse biobanks in the U.S. (n ~ 50,080
) as external population controls. We
proposed in Aim 1, to identify rare and low-frequency, pathogenic variants in associated with LC risk in AAs; and
Aim 2, to evaluate common, pathogenic variants associated with LC risk in AAs.
Given the high genetic diversity in AAs, genetic analysis of this understudied population would facilitate new risk
locus and pathogenic variants discovery that has not been previously found in EA studies, including those that
are specific to African-ancestry populations or shared across divergent populations. Results from this family-
based study will provide a database that can be mined for future studies of genetic differences in AAs. Identifying
novel pathogenic variants in AAs will serve as a starting point to help future targeted LC screening and
personalized risk assessment for AAs and will move us closer to the elimination of health disparities.

Public health relevance
Public Health Relevance Despite an overall lower tobacco exposure, African-Americans have the highest burden of lung cancer in the U.S. of any racial/ethnic group. Findings from this project could contribute significantly to our understanding of the genetic susceptibility of lung cancer among African-Americans. This research will help explain why lung cancer affects African-Americans more often than European Americans and will potentially lead to new and improved modes of diagnosis and prevention for patients with lung cancer among African-Americans.